Administration: meetings, education, outreach, website management

PROJECT SUMMARY (See instructions): The Harvard University Conte Center Administrative Core will be charged with the overall management and administration of the center and its objectives. The Administrative core will facilitate communications between the projects and cores, as well as with the University and outside programs/entities that will benefit from the research and progress made at the Conte Center. A fulltime Center Administrator will be responsible for overseeing and managing the center's budget, events (including but not limited to Public Outreach, Training, and Advisory Board events), website development, and planning programs for training, public outreach and the Conte Center Summer Program, as well as day-to-day operations. To foster education about mental illness and integration across Conte Center laboratories, a Journal Club and website will be established. In addition to disseminating knowledge, the Conte Center will also reach out to under-represented minority students more specifically by online/mobile Cyber Labs in conjunction with summer program students and teachers. Advisory board members each year will be asked to give a major public lecture at one of the Harvard University lecture halls to be advertised broadly in conjunction with the Harvard Center on the Developing Child.

Public health relevance
RELEVANCE (See instructions): By leveraging our unique position at the undergraduate campus of Harvard University, we hope to maximize impact on public awareness and to nurture the next generation of mental health researchers.